Deep LOGISMOS: Hippocampal Plasticity in Alzheimer's Disease (Admin. Supplement)

This project proposes an administrative supplement to our research project titled “Deep LOGISMOS”
(R01-EB004640) for further development of our general-purpose segmentation of multiple interacting
objects and surfaces to efficiently facilitate quantitative studies of targeted-exercise effect on human
hippocampal morphology and radiomic features. This supplement extends the applicability of Deep
LOGISMOS + JEI to Alzheimer's disease (AD) research. Our work will focus on the role of aerobic exercise
on decreasing the pace of cognitive decline in AD or perhaps preventing such a decline altogether. It is
well known that left/right hippocampus, one of the deep anatomical structures in the brain, and its
subregions play a critical role in AD development. It is equally accepted that management or possibly
treatment of AD progression must start prior to emergence of severe symptoms.
Research study data available from the currently active project R01-AG055500 “Exercise to improve
hippocampal connectivity and learning in older adults” will be used for method development as well as
validity assessment of the overarching hypothesis that moderate to vigorous intensity exercise affects
hippocampal morphology and/or hippocampal radiomic features vulnerable to aging and AD more than
lower-intensity training in a pre-Alzheimer cohort.
The following main aims will be accomplished within 12 months of this research project supplement:
1) Develop and validate Deep LOGISMOS + JEI method for longitudinal 3D+time segmentation of
left/right hippocampus and its six subregions in baseline/follow-up MR image pairs.
2) Develop statistical models capturing left/right/joint/subregional hippocampus
morphology/radiomics changes between baseline and follow-up for each of the two studied
exercise training groups.
3) Determine whether and the extent to which higher-intensity exercise training is more strongly
associated with changes of the left/right/joint/subregional hippocampus morphology and
radiomics.
Our results will be significant because early prevention has the biggest impact. Determining how
exercise counteracts mechanisms of AD-related dementia and cognitive aging leads to understanding
how such plasticity is possible and informs prevention strategies. The proposed work is innovative
because the new Deep LOGISMOS + JEI segmentation will enable our team to test how exercise affects
cognition by bringing together sensitive measures of training induced changes in hippocampal
morphology, hippocampal-dependent learning and memory processes, and novel conceptualizations for
how to capture the physiological changes induced by exercise regimens.

Public health relevance
This “Deep LOGISMOS: Hippocampal Plasticity in Alzheimer’s Disease (Admin. Supplement)” is devoted to redesigning and extending our general-purpose software environment for n-dimensional medical image segmentation (Deep LOGISMOS) to support Alzheimer’s disease (AD) research. As a result of this Supplement, Deep LOGISMOS + JEI methodology for multi-object multi-surface segmentation will newly provide a 3D+time MR image analysis tool for accurate segmentation and shape/radiomics change analysis of the human hippocampi and their subregions. Our image analysis approach will be used to test an important Alzheimer's disease prevention hypothesis that proper exercise can help delay or prevent AD onset by preserving the structure and function of the hippocampus.